Face De-Identification for Research and Clinical Use

DESCRIPTION (provided by applicant): This application addresses NIH's call to promote data sharing and patient privacy. A major obstacle to sharing of recorded video has been the need to protect participants' identity. Similarly, concern about stigma is a reason that many people in need of mental health services (e.g., in the military) fail to do so. We propose a system to de-identify patients and research participants in video. Face de-identification transfers facial expression automatically from source face images, which are confidential, to target face images, which are not. The system safeguards face anonymity while preserving the facial expression of the original source video. The target video then can communicate the emotion, communicative intent, pain, and neurological or physiological status of the source person without displaying the source person's face. Face de-identification would enable video archive sharing among researchers and clinicians without compromising privacy or confidentiality. Moreover, a version of this system could potentially be used to preserve privacy and anonymity in internet-based interviews. Innovation. The project has four innovations. The approach (1) Removes identity information while retaining facial dynamics; thus preserving the information value of the face to communicate emotion, pain, and related states. (2) Accommodates subtle and spontaneous facial actions, rather than imitating only some predefined molar expressions (e.g., happy or sad). (3) Requires no training steps by target persons. (4) And requires no hand annotation of video. The system is entirely automatic. Approach. The software will take as input a video with the face of a subject (source) and automatically generate or output a video with the face de-identified. The project will use new machine learning and computer vision algorithms for transferring subtle facial expression from a source subject (original video) to a target subject, using only one frontal image of the target subject. A major novelty of the approach is to make the process completely automatic. The algorithm will be validated using commercially available software for face recognition and custom software for facial expression analysis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Sharing of video recordings for research and clinical uses would significantly contribute to scientific discovery and patient diagnosis, treatment, and evaluation. We will develop and validate a fully automatic system that preserves facial expression in video while fully protecting face identity.